Center for Collaborative Research in Health Disparities

SUMMARY / ABSTRACT - OVERALL
The goal of the RCMI Center for Collaborative Research in Minority Health and Health Disparities (CCRHD) at
the University of Puerto Rico Medical Sciences Campus (UPR-MSC) for the next five years is to contribute to
the national infrastructure and the capacity for research in the health sciences by supporting translational
studies in health disparities affecting the Puerto Rican population. Toward this end, the CCRHD proposes the
following specific aims: (1) target specific minority health and health disparities areas for development, and
provide initial funding for research activities to support them; (2) promote the professional development of new
faculty and early-stage investigators working in these areas (3) develop an efficient and agile research structure
to provide services that will facilitate the conduct of collaborative research in minority health and health
disparities and (4) establish and nourish long-lasting partnerships with commumity-based organizations. We
will leverage current research infrastructure and relationships with community-based organizations and
stimulate new collaborations utilizing the resources provided by the RCMI Coordinating Center (RCMI-CC) and
other NIH-supported research and mentoring networks such as the CTSA and NRMN. The CCRHD will
integrate its five components into a cohesive structure to address the proposed specific aims and ensure that
research activities focus on minority health and health disparities. The Administrative Core, directed by the
PI, will oversee and support all core activities and provide direction at a program level. Special attention will be
given to the development of career enhancement activities that will promote minority health and health
disparities research. With the assistance of an external evaluator progress of the cores toward achieving goals
and outcomes will be monitored and evaluated. Preservation of on-going collaborations and partnerships, as
well as the development of new ones, will also be a priority.The Research Infrastructure Core will provide
specialized research services in the areas of informatics/data science, genomics, proteomics, tropical and
emerging infectious diseases, and neurogenomics-bioimaging to the RCMI-supported research projects as
well as other research projects addressing minority health and health disparities. The Investigator
Development Core, by supporting pilot projects, will serve as a focal point for promoting professional
development of new faculty and early-stage investigators working on diseases that disproportionately affect
the Puerto Rican population. The Community Engagement Core, will target the development of long-term
partnerships with commumity organizations and facilitate the dissemination of CCRHD services and research
achievements. Finally, we will support three translational Research Projects, conducted covering the areas
of basic biomedical, behavioral and clinical research. All research projects address mechanisms and/or
develop and evaluate interventions to reduce health disparities relevant to the Puerto Rican population.

Public health relevance
Project Narrative The proposed Center for Collaborative Research in Health Disparities (CCRHD) at the University of Puerto Rico Medical Sciences Campus builds upon research resources developed under a previous RCMI-U54 grant and an extensive academic/community partnership to address health disparities affecting the Puerto Rican population. Translational research projects in the areas of basic biomedical, behavioral and clinical research, if successful, will provide different and innovative approaches to increase the capacity to conduct word-class research on diseases that disproportionally affect the Puerto Rican population by enhancing participation of Hispanic patients in clinical studies, partnering with community organizations and enabling all level of investigators to conduct health disparities research.